STrengthening Research OpportuNities for Growth at Meharry Medical College (Meharry-STRONG)

Project Summary/ Abstract
The goal of the STrengthening Research OpportuNities for Growth at Meharry Medical College (Meharry-
STRONG) Program is to assess research capacity and develop an institution-wide action plan to meet our
specific needs identified. We hypothesize that first developing an infrastructure that supports engaged
evaluation of our research capacity will allow us to perform high quality needs assessment and develop an
action plan that truly permits capability enhancement. In Aim 1, we will engage stakeholders before developing
and administering the needs assessment, which includes both qualitative and quantitative tools. In Aim 2, we
will analyze results and interpret data based on topic areas: administrative, research, and faculty and student
development. In Aim 3, we will formulate an institutional action plan that incorporates interventions to build
capacity at Meharry. The plan will provide a detailed roadmap for enhancing our research infrastructure and
capacity using step by step additions to gradually and progressively build on past successes to generate
momentum. Accomplishment of our aims will provide Meharry with an actionable and realistic plan to increase
competitiveness in the biomedical research enterprise and foster an environment conducive to developing
research careers for our trainees and faculty.

Public health relevance
Project Narrative The Meharry STRONG Program is designed to systematically assess current research capacity and strengths, identify critical gaps and barriers, and develop evidence-based action plans to address top priorities. The outcomes of our assessment will be the identification of capacity-building interventions that we can undertake to strengthen our research framework and capacity.